NIAID- VRC HIV mAb-Research, Development, and Production to Support HIV Monoclonal Antibody Development

The NIAID mission and scope includes rapidly responding to infectious disease outbreaks through research, development, and testing of HIV vaccines and therapeutics